GALLBLADDER EMPTYING KINETICS IN GALLSTONE PATIENTS--NONSURGICAL TREATMENTS

To establish and validate cholescintography; to compare gallbladder emptying kinetics before and after nonsurgical treatments; and to evaluate the recurrence of gallstones or retained residual following dissolution as related to emptying kinetics.